Noninvasive assessment of renal fibrosis in kidney transplant recipients bymulti-contrast magnetic resonance imaging

Project Summary
Kidney transplantation is considered the treatment of choice for patients with end-stage renal disease. While
short-term kidney transplant outcomes are excellent, late renal allograft loss remains an important clinical
problem. The most common cause of kidney graft failure after the first year is chronic allograft dysfunction, which
is characterized by a progressive loss of graft function with development of interstitial fibrosis and tubular atrophy.
Moderate to severe forms of interstitial fibrosis are found in 66% of patients at 5 years after transplantation,
increasing to 90% at 10 years. Although kidney biopsy remains the gold standard to detect and quantify renal
fibrosis, it is an invasive procedure, and thus not suitable for routine monitoring of kidney graft health.
This research proposal aims to address the clinical need for noninvasive biomarkers of renal allograft fibrosis
by (i) providing a new magnetic resonance imaging sequence (MT-DWI) that combines diffusion measurements
(DWI) with magnetization transfer (MT) contrast to sensitize the DWI signal to the elevated macromolecular
content in fibrotic kidney transplant, and (ii) applying intravoxel incoherent motion (IVIM) analysis to concurrently
assess the vascular/tubular flow and microstructural integrity. The overarching goal of this proposal is to improve
the sensitivity and specificity of MRI to interstitial fibrosis.
Implementing this novel MRI method for applications in kidney transplant recipients will require expertise in
DWI and MTI methodology, MR pulse sequence programming, renal physiology, and clinical research design
and conduct. Following a comprehensive training in these areas, three specific aims will be pursued:
Under Aim 1, I will develop an MT-DWI pulse sequence for 3-Tesla MRI scanners and establish a clinically
feasible acquisition protocol. Under Aim 2, I will assess repeatability and robustness of the proposed method in
10 renal allograft recipients. Under Aim 3, I will evaluate the potential clinical value of MT-DWI for detecting renal
fibrosis in 72 kidney transplant patients referred for renal allograft biopsy. I hypothesize that the proposed
technique will correlate better with the severity of interstitial fibrosis and will have higher sensitivity and specificity
to renal fibrosis than eGFR and conventional DWI.
The Pathway to Independence Award will be supported by excellent resources at Kennedy Krieger
Institute and Johns Hopkins University, and training from a mentoring team of globally recognized leaders in the
fields of MRI, renal physiology, and clinical and translational kidney research. The immediate impact of my
research proposal will be a new way to non-invasively detect and assess the severity of fibrosis in renal transplant
patients, potentially allowing for longitudinal monitoring and treatment evaluation.

Public health relevance
Project Narrative Chronic allograft dysfunction associated with progressive interstitial fibrosis and tubular atrophy is the major cause of kidney transplant failure despite improvements in immunosuppression. The proposed research will develop a novel multi-contrast magnetic resonance imaging method that can provide sensitive and specific measures of renal allograft fibrosis. Such imaging biomarkers will enable non-invasive staging and longitudinal treatment monitoring of renal fibrosis and therefore contribute to improved management of kidney transplant patients.